Defining sex differences in GABA regulation of dopamine release in cocaine use disorder

Project Summary/Abstract
Although males and females both suffer from cocaine use disorder (CUD), females represent a particularly
vulnerable population and the neural mechanisms underlying this sex difference remain poorly understood. CUD
is characterized by cocaine-induced alterations in dopamine release in the nucleus accumbens (NAc). Sex
differences in dopamine release and its regulation in the NAc has also been linked to sex-specific behaviors in
CUD. The goal of this proposal is to define sex differences in dopamine release regulation in the NAc and
determine how this process is dysregulated following cocaine self-administration. GABA-A and GABA-B
receptors in the NAc have been linked to the reinforcing properties of cocaine. Further, GABA is a key regulator
of dopamine release through direct actions of GABA receptors on dopamine terminals in the NAc. However,
long-term plasticity in GABAergic regulation of terminal dopamine release is unknown, and sex-differences in
this process have been virtually unstudied. The goal of this proposal is to define sex differences in GABAergic
regulation of dopamine release, determine if cocaine self-administration alters this regulation in a sex-specific
fashion, and examine the causal role of GABA-A and GABA-B receptors in cocaine-induced plasticity in the NAc.
In Aim 1, I will use ex vivo optical recordings in the NAc with a genetically encoded dopamine sensor (dLight1.2)
to record evoked dopamine release in males and females. Using pharmacology, I will investigate GABA-A and
B receptor regulation of dopamine release and determine if sex differences exist. Based on my preliminary data,
I hypothesize that GABA-A-mediated inhibition of evoked dopamine release will be sex-dependent, with greater
effects in males. In Aim 2, I will investigate cocaine-induced plasticity in this regulation following cocaine self-
administration in mice. In Aim 3, I will knock out GABA-A and GABA-B receptors in dopaminergic neurons and
determine if these receptors are necessary for cocaine-induced plasticity in dopamine release in the NAc. Taken
together, the experiments in this proposal will be the first to define sex-differences in GABAergic regulation of
dopamine release in the NAc, determine how these processes are altered by cocaine self-administration, and
investigate the roles of GABA receptors in cocaine-induced plasticity in NAc dopamine release. This proposal
encompasses technical and theoretical training that will provide the foundational expertise and conceptual
thinking needed to address larger questions regarding how drug-induced and sex-specific changes in the brain
support the development and sustainment of CUD. Additionally, these findings can ultimately inform our
understanding of sex-specific mechanisms underlying reward and learning process and lead to more efficacious
treatment interventions for males and females.

Public health relevance
Project Narrative Men and women are differentially vulnerable to the development and sustainment of cocaine use disorder, and women represent the population most at risk. Dysregulation of the dopamine system is critical in the expression of sex-specific behaviors implicated in addiction. Results from this project will characterize sex-differences in the regulation of dopamine release and will provide a better understanding for pharmacotherapeutic approaches for SUD treatment in both males and females.